Repurposing Siponimod for Alzheimer's Disease

SUMMARY/ABSTRACT
Repurposing Siponimod for Alzheimer’s Disease
Alzheimer’s disease (AD) is a neurodegenerative disorder with several complex neuropathologies suspected to
develop sequentially but that overlap over time as symptoms progress to dementia. Thus, to be effective, future
intervention strategies will likely require combination therapies or pleiotropic agents to tackle several AD
molecular pathogenic pathways simultaneously. For more than a decade, our group has been exploring the
repurposing of immunomodulators for AD. Recent discussions with collaborators specialized in multiple sclerosis
suggest that sphingosine-1-phosphate receptor (S1PR) modulators are strong candidates for repurposing in AD.
Indeed, S1PR modulators are blood brain barrier (BBB) penetrant and display pleiotropic actions, including
immunomodulation and neuroprotective properties. S1P is a versatile endogenous molecule that regulates
several signaling pathways by binding to five G-protein-coupled receptors, which are expressed in high levels in
cardiac, vascular, immune, and brain cells. This widespread localization of S1PR was the historical basis for
Novartis Pharmaceuticals, Inc, to develop oral formulations of S1PR modulators for multiple sclerosis (MS),
which proved successful and resulted in two marketed compounds. In the present project, we intend to
collaborate with Novartis to use the most recently FDA-approved S1PR modulator siponimod. Based on MS and
animal experimentation literature, we hypothesize that siponimod could lower the rate of brain atrophy in AD
subjects. In this Phase II, proof-of-concept, rigorous translational clinical study, mild AD subjects will be
randomized 2:1 and receive a slow up-titration regimen of siponimod up to 1 mg/day (N=70) or placebo (N=35)
for 12 months, followed by a 6-month washout period. Primary objectives are drug safety and tolerability in AD
subjects assessed via regular clinical tests throughout the dosing period. Critically, eventual treatment-emergent
toxicities will drive our go/no-go decision process to pursue or stop dosing. The secondary objective is to
determine drug effect on relative annual brain atrophy rates in the two groups by comparing pre- and post-
exposure volumetric MRI data. Tertiary objectives are cognition and CSF markers of AD (amyloid, tau, p-tau)
and inflammation. As an exploratory objective, we will also investigate whether blood cell counts and blood
biomarkers can be used as dynamic surrogate markers of drug efficacy. Because siponimod has demonstrated
positive immunomodulatory and neuroprotective actions in MS, and because its toxicity profile is favorable for
use in older individuals, this drug has a strong potential to alter markers of AD pathology and disease trajectory.

Public health relevance
NARRATIVE Repurposing Siponimod for Alzheimer’s Disease In the present translational proof-of-concept clinical trial, we use an innovative design putting a strong emphasis on safety and tolerability to repurpose the immunomodulatory and neuroprotective multiple sclerosis drug siponimod on mild Alzheimer’s disease (AD) subjects. More precisely, we will use an adapted up-titration regimen and carry out volumetric MRI as a proxy for neurodegeneration; plus we will measure cognitive markers and several CSF and blood biomarkers to assess whether 12 months of siponimod exposure can alter disease trajectory in AD subjects.